Individual, cultural, and area-based factors associated with survivorship care among Asian/Asian American childhood cancer survivors

With treatment advances for childhood cancer, over 80% of patients achieve long-term survival. However, cancer treatments often lead to other serious issues, including chronic health problems and early mortality. These health problems are referred to as “late effects,” defined as any adverse medical or psychosocial outcome that develops or persists after treatment. By 25 years following treatment, over two-thirds of childhood cancer survivors (CSS) have developed at least one clinically significant late effect, with over one-third developing one or more severe or life-threatening late effect. As a result, life-long cancer-focused long-term follow-up care (LTFU) is essential for CCS to screen for, prevent, and treat late effects. Our current understanding of among CCS comes primarily from a cohort of adult CCS diagnosed between 1970 and 1986 (The Childhood Cancer Survivor Study-CCSS) which is comprised of predominantly white survivors. However, studies have shown that CCS from other groups experience significant health challenges, and thus more research is required to understand their issues to address and reverse them. Rates of LTFU and factors influencing cancer-focused care among Asian American (AA) CCS are unknown. AA populations represent the fastest growing group in the United States, with 59% of the US Asian population born in another country. This group is socioeconomically heterogenous and has grown 72% between 2000 and 2015 is projected to grow to more than 10% of the US population by 2050. Thus, the number of AA CCS is expected to increase, and a greater focus on facilitators and barriers to LTFU is needed in this population. Further, many Asians live in neighborhoods with a high concentration of residents who share similar backgrounds (“enclaves”) which may influence engagement in LTFU for AA CCS. We propose to recruit a population-based cohort of roughly 330 young adult AA CCS and their parents (N=100) in Los Angeles and Orange Counties to examine factors related to survivorship care utilization. Our aims are: Aim 1: We will characterize on a population basis the utilization of cancer-focused survivorship care among Asian CCS. Aim 2: We will examine through qualitative interviews and survey methods individual- and family-level factors associated with the utilization of cancer-focused survivorship care among AA CCS and their parents. Aim 3: We will investigate the effect of residing in an enclave on the utilization of LTFU. The proposed research will provide guidance to identify and address needs among AA CCS for survivorship care utilization to increase outreach and intervention strategies to engage and retain these CCS in care.

Public health relevance
Asian populations are the fastest growing group in the United States. Rates of childhood cancer are rising in these populations more rapidly than in others. However, Asian American survivors are under-researched. This study will examine the individual, family, and neighborhood factors associated with cancer-focused survivorship care among young adult Asian American childhood cancer survivors to foster healthy survivorship for this patient population.